A clinician-in-the-loop smart environment to support management of chronic health conditions

PROJECT SUMMARY / ABSTRACT
As the population of individuals 65+ grows, so too will the number of individuals who struggle to manage
chronic health conditions. Exacerbations, or sudden symptom worsening, of chronic conditions place a burden
on the health care system and cause decreased quality of life and accelerated decline. Forecasting health
exacerbations can prevent life-threatening events or limit their impact. The long-term goal of this work is to
create a clinician-in-the-loop (CIL) smart environment that empowers individuals in managing their chronic
health conditions. Our proposed CIL framework partners clinical expertise with pervasive computing and
machine learning. In this system, sensor data are collected continuously by ambient and wearable sensors. Our
ML algorithms extract behavior markers to show to a clinician. Behavior changes are detected due to internal
(i.e., condition exacerbation) or external (i.e., wildfire smoke, shutdown due to COVID-19 pandemic) events.
Trained by clinicians, prediction of future condition exacerbations and health states are generated with
corresponding reliability scores. Correspondingly, clinicians will provide summaries of observed behavior,
reasons to confirm likely exacerbations, and recommendations to prevent health events. These summaries are
used to train a language model that will provide interactive explanations of future data and ML predictions.
Data are collected continuously by ambient sensors in the smart home and wearable sensors in Apple watches
to validate the findings and provide more complete monitoring. From smartwatch sensors, we will analyze the
predictive relationship between external events, social determinants of health, socialization, environment
quality, behavior, and health state. The result of these steps is an automated technology that can assist with
self-management of chronic conditions and monitor the impact of interventions. The proposed aims will be
validated using data collected in our prior study for n=44 older adults and in a new data collection with n=20
older adults. Participants in the restrospective study with historic data and prospective study with new data will
be older adults age 50+ living in independent homes who are managing one or more chronic health conditions.
Expanding the smart environment to encompass ambient sensors and wearable sensors increases the
accessibility of the technology for underserved communities and, when used in combination, improves model
robustness through joint prediction. Although clinical oversight of patient health will always be valuable, the
technology can provide an “informatics triage” that allows a clinician to remotely monitor a greater number of
individuals at a time and provide valuable information to the individual to assist in self-management.
Outcomes of this proposed study include open-source software for forecasting condition exacerbations,
software to train language models from clinician input, and the corresponding trained models; results of
analyses linking external influences, socialization, behavior, and health; apps for collecting ambient and
wearable data; and data that will be prepped for integration into the NIH RWDP platform.

Public health relevance
PROJECT NARRATIVE To meet the needs of the growing adult population who manage chronic health conditions, we propose to enhance our clinician-in-the-loop smart environment to prevent and treat condition exacerbations. We will design conformal prediction methods to forecast future exacerbations. Additionally, we will analyze the impact of external events like the COVID-19 pandemic and frequent wildfires on behavior, socialization, environment, and health state. For all of our machine learning tasks, we will train language models from nurse summaries to provide text explanations of observed behavior and machine learning predictions.